Improving the Timeliness and Equity of Adjuvant Therapy Following Surgery for Head and Neck Cancer

PROJECT SUMMARY/ABSTRACT
The goal of this K08 proposal is to provide the candidate with a framework to develop a comprehensive research
program as a surgeon scientist investigating multi-level, theory-based interventions to improve the timeliness,
equity, and quality of head and neck cancer (HNC) care delivery. HNC is a disease with poor survival despite
intense therapy with surgery, radiation, and chemotherapy. HNC is also a disease with significant racial
disparities in mortality; African Americans (AAs) have a 51% relative decrease in survival compared to whites.
Delays starting postoperative radiation therapy (PORT) after HNC surgery are a key driver of high mortality and
racial disparities in survival and thus an appealing therapeutic target to address both issues. Delayed, non-
guideline-adherent PORT initiation affects 56% of HNC patients, is 31% more common in AAs, associated with
an 11% absolute decrease in 5-year survival, and a key contributor to racial differences in mortality. Although
delivering timely PORT is of critical importance to prevent excess mortality and racial disparities in survival,
effective interventions to improve the rate of timely, equitable PORT are lacking, in part due to the gap in our
understanding of the relevant barriers in this population. In this proposal, the candidate will develop, pilot-test,
and evaluate the preliminary clinical impact of NDURE (Navigation for Disparities and Untimely Radiation
thErapy), a novel theory-based PN intervention to improve timely, equitable PORT in HNC patients. The
research objective is to evaluate the preliminary clinical impact of NDURE on delays and racial disparities starting
PORT among HNC patients. The central hypothesis is that NDURE will decrease PORT delays and racial
disparities in delay by improving care coordination, self-efficacy, interpersonal support, and knowledge. Specific
Aim 1 will identify the multi-level barriers that contribute to delays starting PORT after HNC surgery through key
informant interviews with HNC patients and providers. Specific Aim 2 will assess the feasibility and acceptability
of NDURE in a single-arm pilot study. Specific Aim 3 will test NDURE in a pilot randomized controlled trial (RCT)
to evaluate its preliminary clinical impact on delays starting PORT among white and AA HNC patients. Ultimately,
this research will have a large scientific impact by enhancing our conceptual understanding of timely, equitable
multimodal HNC care delivery. It will have a significant clinical impact through the development of a scalable and
practical intervention to decrease delays and racial disparities starting PORT, thereby improving survival for HNC
patients and decreasing racial disparities in mortality. The training objective is to address the candidate’s
scientific gaps in cancer health disparities, qualitative research, health systems and interventions research, and
clinical trial design and analysis through mentored scientific training integrated and aligned with his research.
Completion of the research and scientific training will position the candidate well to lead research investigating
multi-level, theory-based interventions to improve the timeliness, equity, and quality of HNC care delivery.

Public health relevance
PROJECT NARRATIVE Head and neck cancer is a disease with poor survival, especially for African Americans, despite intense treatment including surgery, radiation, and chemotherapy. Delays between surgery and the start of postoperative radiation therapy are common, cause excess mortality, and contribute to worse survival in African Americans. Our research team has identified a promising approach to minimize delays starting radiation after head and neck cancer surgery that could provide the first effective intervention to improve timely, equitable care in this patient population, thereby improving survival for patients with head and neck cancer, decreasing racial disparities in mortality, and developing new standards of clinical care. 1